Therapeutic implication of RB1 loss in bladder cancer

Abstract
This proposal describes a 5-year research career development program focused on a non-canonical role of RB1
loss in bladder cancer. Dr. Qiang Li is an Assistant Professor of Oncology at Roswell Park Comprehensive
Cancer Center in the Department of Urology. The proposal builds on the candidate’s previous experience and
current research projects using genetically engineered mouse models (GEMMs) and organoids. The proposed
experiments and training will enable his transition to independence as a physician scientist in bladder cancer
translational research. He will be mentored primarily by Dr. David Goodrich. Dr. Goodrich is an expert in RB1
cancer biology, genetically engineered mouse models, acquired drug resistance and cancer cell plasticity. The
training plan includes the following goals: (1) Enhance expertise in preclinical cancer modeling (GEMM and
organoids); (2) Probe the molecular mechanisms of bladder cancer cellular plasticity and drug resistance; and
(3) Gain expertise in bioinformatic analysis.
RB1 mutations are predictive of pathologic response after neoadjuvant chemotherapy in bladder cancer. Other
clinical observations suggest that the basal type of bladder cancer is more likely to respond to chemotherapy
than the luminal type. However, the biological impact of RB1 loss on molecular subtypes of bladder cancer
pathogenesis and chemotherapy response has not been investigated. Newly discovered features of the RB1
pathway in other cancer types suggest that RB1 loss promotes lineage plasticity and acquired therapy
resistance. Thus, we hypothesize that RB1 loss promotes bladder cancer progression, metastasis, and cellular
plasticity (luminal to basal, and therapeutic resistance). We use two transgenic mouse systems (Uroplakin II
driven reverse tetracycline trans-activator, TRE-Cre) to investigate the role of RB1 loss in bladder urothelium by
facilitating deletion of tumor suppressor genes (Trp53, Pten, Rb1) under control of doxycycline administration.
We engineered doxycycline inducible triple knockout mice Trp53-/-: Pten-/-: Rb1-/- (referred as TKO) and double
knockout mice Trp53-/-: Pten-/- (referred as DKO). We propose the following Specific Aims: (1) Define the function
of RB1 loss in accelerating tumor progression, metastasis, and cellular plasticity in bladder cancer GEMMs; (2)
Dissect the impact of cell-of-origin on bladder tumorigenesis, metastasis and response to chemotherapy in TKO
tumors derived from basal cells versus luminal cells. Successful completion of this proposal will allow the
candidate to gain valuable technical knowledge and expertise in preclinical modeling of advanced bladder cancer
and further his development as an independent physician scientist. The work will also establish experimental
models and analysis pipelines that will provide the foundation for the candidate’s independent research program.

Public health relevance
Project Narrative The role of RB1 loss in bladder cancer progression, differentiation and cancer cell plasticity remains unknown. A major obstacle in translational bladder cancer research is the lack of genetically engineered mouse models that recapitulate aggressive muscle invasive bladder cancer in humans, that makes it difficult to rigorously study in vivo responses to systemic treatment. The proposed research will utilize novel mouse models to elucidate the role of RB1 loss in tumor progression, differentiation, plasticity and resulting clinical therapeutic implications.